Culturally Adapting Adolescent Dialectical Behavior Therapy for Alaska Native Adolescents

Alaska Native and American Indian (AN/AI) youth constitute the highest risk population for suicidal
thoughts and behaviors (STBs) of all racial/ethnic groups in the US, primarily due to colonization, historical
trauma, and lack of access to culturally responsive evidence-based interventions (EBIs). This is particularly
true in Alaska, where the suicide rates among Alaska Native (AN) youth are over 10x higher than those of their
non-AI/AN counterparts nationwide. In addition to contextual risk factors faced by all residents of Alaska (e.g.,
limited sunlight, cold climate), AN youth are impacted by the ongoing consequences of intergenerational,
historical, and culture-based trauma, including disproportionate exposure to adverse childhood experiences
(e.g., parental substance use), community exposure to suicide, loss of land, and discrimination. This long
history of systematic oppression has been identified as a primary driver of the disparities in STBs observed in
AN vs. non-AN youth living in Alaska. Adolescent Dialectical Behavior Therapy (DBT-A) is a family-based,
principles-driven, third-wave form of cognitive behavioral therapy that incorporates acceptance- (e.g.,
mindfulness) and change-based (e.g., emotion regulation) strategies to help emotionally dysregulated
adolescents build “lives worth living.” Although DBT-A constitutes the most efficacious EBI for multi-diagnostic
youth experiencing STBs, AN youth have been largely excluded from prior DBT-A trials, precluding a true
evaluation of the potential fit or efficacy of DBT-A for this high-risk population. DBT-A is a strong candidate for
cultural adaptation due to the lack of AN representation in prior trials; diversity with respect to etiological factors
driving STBs among AN peoples; and its inherently multicultural dialectical philosophy, which consistent
with AN tradition. Culturally-adapted EBIs result in increased acceptability and efficacy and are up to five times
more likely to result in clinical remission. To fill these gaps and address a major health inequity, the goals of
the current study are to: 1) partner with the AN community and elucidate key factors driving STBs among AN
youth as well as barriers and facilitators to implementation of the intervention; 2) iteratively adapt DBT-A in
collaboration with AN youth and community stakeholders; 3) conduct a pilot RCT trial (N = 48) of the adapted
“DBT-A-AN” intervention vs. Enhanced Treatment As Usual to examine acceptability, feasibility, and
preliminary clinical outcomes, mechanisms, and culturally-relevant protective factors. The proposed K23 will
further solidify the applicant’s expertise in DBT/STBs and facilitate her development as an independent
investigator via training in qualitative and mixed methods for intervention development and cultural adaptation;
community-engaged clinical trials methodologies; and Alaska Native history, culture, health, and ethics. This
study is directly aligned with NIMH’s new Strategic Framework on Youth Mental Health Disparities and Priority
1 of NIMH’s health disparities agenda: “to investigate ways to reduce suicide and suicidal behavior among
specific underserved and minoritized populations.” Results will inform a fully-powered trial of “DBT-A-AN.”

Public health relevance
Project Narrative Compared to their non-Native counterparts nationwide, Alaska Native (AN) adolescents are up to ten times more likely to experience suicidal thoughts and behaviors (STBs). These health inequities are largely due to the ongoing physical, spiritual, and psychological impacts of historical, intergenerational, and culture-based trauma endured by AN peoples (e.g., colonization). Directly aligned with NIMH’s Strategic Framework on Youth Mental Health Disparities, the overarching aim of the proposed mixed methods study is to co-create, pilot, and evaluate the feasibility of a culturally-adapted version of Adolescent Dialectical Behavioral Therapy (DBT-A) tailored for, by, and with AN youth and community members.